Yale-Drug use, Addiction, and HIV prevention Research Scholars (Yale-DAHRS)

7. Project Summary/Abstract
We request a 2nd renewal for our 5-year Yale Drug use, Addiction and HIV prevention Research Scholars
(Yale-DAHRS) program which has been providing intensive research training and career development for
physician scientists (scholars) focusing on research in medical settings since 2013 with high impact
results. The Yale-DAHRS program has successfully recruited 10 diverse scholars (7 women and 2 URiM)
representing multiple physician disciplines, including Emergency Medicine, General Internal
Medicine/HIV/Hepatology/Pulmonary, Pediatrics/Adolescent Medicine and Obstetrics and Gynecology,
covering the patient life span in a wide range of medical settings and populations. Patients with pre-addiction
and substance use disorders often receive medical care for a complex array of acute consequences and
complications of substance use and chronic conditions in medical settings such as emergency departments
and primary care and specialty clinics. The Yale-DAHRS program provides a comprehensive three-year post-
doctorate, interdisciplinary Mentored Career Development Program that incorporates a robust didactic
research curriculum leading to a Masters in Health Science degree, mentored research and training in topics
related to Addiction Medicine to: [Aim 1] Develop physician scientists with the knowledge and skills to
become independent investigators, generating novel findings to improve drug use and addiction outcomes
through prevention and treatment in medical settings. [Aim 2] Develop future leaders by providing scholars
with skills to ensure success in leading multidisciplinary teams in studying prevention & treatment of drug use
and addiction and their implementation and integration into medical settings; and [Aim 3] Enhance the
diversity of drug use and addiction researchers, and robustly address health equity in all stages of
addiction research. Addressing the representation of women and URiM faculty in the physician scientist
workforce will enhance the diversity of investigators and research topics, broaden perspectives in setting
research priorities, increase trial participation, and expand knowledge. Our program has demonstrated success
capitalizing on the synergies of established training and clinical programs at Yale and our community partners,
and the experiences offered by our seasoned, diverse group of interdisciplinary core faculty, mentors and
advisory committee. Our graduates are all on faculty research tracks, and recognized leaders in their
respective fields. Seven are boarded in Addiction Medicine. They have published and disseminated their
research findings widely, and are all federally funded. This renewal will continue support for 2 current scholars
and will also support 3 new scholars. The proposed renewal benefits from iterative changes to Yale-DAHRS
over time including the addition of formal leadership training/coaching and new approaches to addressing
diversity, equity and inclusion in research to identify disparities and interventions to improve patient outcomes.

Public health relevance
8. Project Narrative Drug use and addiction is a major cause of illness/injury and mortality and patients with or at risk for substance use disorders typically receive medical care for acute consequences and complications of substance use and chronic conditions in medical settings such as emergency departments, primary and specialty care clinics. Thus, these diverse medical settings offer a critical opportunity to prevent and treat drug use and addiction. This proposal seeks to provide intensive research training and career development for a diverse cadre of physician scientists representing multiple disciplines including Emergency Medicine, General Internal Medicine/HIV/Hepatology/Pulmonary, Pediatrics/Adolescent Medicine and Obstetrics and Gynecology, to improve patient outcomes through prevention and treatment in medical settings.